Interactions of Alcohol and Pain in the Context of HIV

Abstract
This NRSA F30 fellowship will prepare the applicant for a successful career as a translational physician-
scientist. Career development training will focus on High Priority HIV/AIDS comorbidity-related research,
utilizing a preclinical rodent model of HIV gp120-induced neuropathic pain alongside investigation of a clinical
population of people living with HIV (PLWH). Alcohol use disorder (AUD) is a chronic disease associated with
excessive drinking and is frequently comorbid in people living with HIV (PLWH). AUD often results in the
emergence of negative emotional states that influence the desire to consume alcohol, and one potentially
important contributor to these negative affective states in PLWH is HIV-associated painful neuropathies (HIV-
N). Thus, the rationale for drinking in PLWH may stem from a desire for self-medication of pain due to the
analgesic properties of alcohol. Importantly, excessive alcohol use can also result in hyperalgesia, a condition
that may be worsened by HIV-N. Previous work has described the emergence of hyperalgesia in animals made
dependent on alcohol. Preliminary investigation in a cohort of PLWH has also revealed positive associations
between AUDIT (Alcohol Use Disorders Identification Test) scores and circulating levels of the stress hormone
cortisol. At the molecular level, the transcriptional activity of glucocorticoid receptors (GRs) is directly controlled
via phosphorylation status. Dysregulation of GR signaling may facilitate the transition to AUD and contribute to
AUD-associated hyperalgesia, potentially playing a role in development of HIV-N. Furthermore, chronic pain
can result in supraspinal plasticity in brain areas linking nociception and negative emotion, such as the
cingulate cortex, which may also contribute to the establishment or progression of AUD. In support of this,
preliminary data has discovered increases in GR phosphorylation in the cingulate of alcohol-dependent rats.
To study the contributions of alcohol and HIV to HIV-N, we’ve utilized an established preclinical rodent model
employing perineural exposure to the HIV envelope protein, glycoprotein 120 (gp120), which is closely involved
in the pathogenesis of HIV-N. Taken together, our preliminary data and the existing literature support the
hypothesis that increased pain associated with HIV and at-risk alcohol use is driven by heightened
glucocorticoid receptor (GR) activity. The proposed study will employ a wide array of techniques to test two
hypotheses: (1) GR activity mediates hyperalgesia associated with HIV gp120 and alcohol dependence in rats
and (2) circulating cortisol levels are associated with pain symptoms and AUD risk measures in PLWH.
Findings from this study will advance our understanding of the role of stress hormone signaling in the interplay
between HIV- and alcohol-associated pain. With the support of a strong mentoring team and the NIH P60
Comprehensive Alcohol-HIV/AIDS Research Center (CARC), completion of the proposed research and training
plan will ensure that the applicant is prepared for an impactful career in academic medicine.

Public health relevance
Narrative This NRSA F30 fellowship will provide an invaluable and comprehensive training opportunity for a future physician scientist as she develops into an emerging leader in the field of HIV/alcohol research and neurology. These studies investigate the contribution of glucocorticoid signaling to interactions between alcohol use and pain in the context of HIV. Findings from this research will provide mechanistic insight for future translational studies and therapeutic applications aimed at alleviating HIV- and alcohol use disorder (AUD)-associated pain.